Plasma tau and neurodegenerative markers as predictors of rate of AD progression

Project Abstract:
Alzheimer's disease and related dementias (ADRD) affect tens of millions of people around the world and
represent a staggering challenge for patients, families, and healthcare systems. For some who present with
mild levels of cognitive impairment, there is rapid worsening of cognition and function, whereas for others, the
rate of progression can be absent or much slower. Understanding this variability in rate of progression is
critically important to patients, families, and clinical researchers alike, and is not well-predicted by common,
clinically available biomarker tools. Blood-based markers of AD pathology and neurodegeneration have
potential for widespread use in clinical research and even clinical care, due to their non-invasiveness, cost
relative to neuroimaging, and lack of medical contraindications to limit their use. Here we examine a set of
newly developed, blood-based AD biomarkers (including neurofilament light chain, phospho-tau species, tau,
and Ab fragments) that may fill this gap. Leveraging prospectively acquired samples from a large clinic
population and from local clinical research studies, we will determine how these plasma measures relate to
variable rates of "real-world" cognitive and functional decline, as well as to imaging-based measures of
neurodegeneration and AD pathologic progression.

Public health relevance
Project Narrative: Alzheimer’s disease (AD) and related dementia syndromes (ADRD) represent an enormous challenge for patients, families, caregivers, and health care systems. Due to availability, cost, contraindications, and a number of other factors, currently available clinical diagnostic tools leave many people presenting with mild memory loss (and their families) with substantial uncertainty regarding their risk and likely rate of progression moving forward. In this project, we assess whether novel blood-based biomarkers of ADRD can be used to improve diagnosis and predict prospective rates of cognitive decline and thereby serve as powerful clinical and research tools.